Advancing Psychosocial and Biobehavioral Stress Measurement and Interventions to Promote Healthy Aging

Project Summary
Strong epidemiological evidence demonstrates that chronic psychological stress predicts earlier disease
onset and mortality. The emerging science of stress is increasingly incorporated into the epidemiological study
of healthy aging and there is greater awareness of the role of social stress. NIA has supported the Stress
Measurement Network to elevate stress research through improved measurement, the use of harmonized
stress measures in HRS Around The World (ATW) studies, and utilizing digital platforms to understand
associations between stress and health in daily life. The Stress Network has made tremendous gains—
providing funding for 29 research teams who have contributed to more than 50 publications toward these
goals. Our stress measurement toolbox is widely used, with over 75,000 unique visitors since we launched our
website. We have accelerated stress science by improving the measurement of lifespan stress exposures and
daily responses grounded in a multilevel approach, a widely adopted approach that our network has
advanced.1 However, given the increases in health disparities and rapid social changes such as climate crises,
social polarization, and political instability, we need new and improved measures of macro stressors as well as
validated interventions that can be scaled to reach minoritized populations.
In our proposed continuation and extension of the network, we build on this foundational work and are
ideally poised to improve and innovate on these products and resources and increase their use. For Aim 1, we
will provide the best practices in psychological and biological stress measurement through (Aim 1a)
implementing webinars, workshops, a podcast (The Stress Puzzle), our expanded online Toolbox of measures
(e.g., existential global stressors, minority stress, cultural measures relevant to stress, resilience, physiological
measures) that may help explain sources of health disparities; use of harmonized stress data in the HRS
studies (Aim 1b), and by building a new toolbox of validated stress-reduction interventions (Aim 1c).
Secondly, we have added a new goal of advancing innovation and validation of stress-reduction
interventions to promote healthy aging of diverse groups. In Aim 2, we will develop a cohesive and supportive
scientific community through webinars on stress measurement and intervention and will develop a national
Stress Network Collaborative (SNC) that will help shape and participate in Aim 2 interventions, and promote
analyses of pre-existing large-scale stress-reduction interventions to understand race/ethnicity and age effects
(Aim 2a). Using the science of behavior change (SOBC) model, we will support pilot studies that measure and
reduce daily stress and recovery (psychological and physiological responses, which are proposed mechanisms
of accelerated biological aging and early disease) (Aim 2b). Lastly, we will launch a mega-study to compare
stress reduction interventions (Aim 2c). These aims will lead to valuable resources and discoveries that will
help transform the field of stress and contribute to public health.

Public health relevance
Project Narrative Chronic stress is common and can impair healthy aging. The Stress Network has improved models and measures of stress, and will continue to advance stress science by: 1) improving and promoting the use of harmonized stress measures that enable us to compare stress and health in ten countries; 2) expanding measures of stress including existential global stressors, culture and minority stress, psychosocial resilience, and physiological stress included in our Stress Measurement Toolbox, and; 3) advancing the science of stress reduction using mobile technology through pilot and large scale digital studies. In turn, this will lead to a deeper understanding of how stress affects disease etiology and progression across the lifespan, as well as effective ways to intervene.